CLONIDINE AND GRF STUDIES IN PATHOLOGICAL ANXIETY AND NORMAL CONTROLS

Growth hormone (GH) responses to agents that perturb the hypothalamic growth hormone axis have been widely used in psychiatric research as a peripheral correlate of central noradrenergic activity. "Blunted" GH-responses to clonidine are generally attributed to post-synaptic noradrenergic receptor down-regulation. In addition to clonidine, we have administered growth hormone-releasing factor (GRF), caffeine, glucose, yohimbine, and TRH to panic disorder patients and normal control subjects. Overall, patients with panic disorder appear to have decreased GH function using a wide array of stimuli that activate the hypothalamic-GH axis. Future studies will investigate the GH response to sleep, exercise, pentagastrin, CI-988, and pyridostigmine.